Developmental Research Project Program

Developmental Research Project Plan – Summary
The Developmental Research Project Plan describes the processes by which competitive awards
to baccalaureate partner institutions (BPI) faculty are requested, reviewed and awarded. This plan is at
the heart of the INBRE and IDeA goals to make network faculty competitive for extramural funding. The
plan is designed to assist network faculty who work in a variety of research areas, from molecular
genetics to human physiology.
In addition to the Project and Pilot Awards (which have been in place for 15 years) and Small
Awards (which have been in place for 4 years), we will implement an Exploratory Award. This award is
for applications which have some merit but are not sufficient for a Project or Pilot Award. The
Developmental Research Project Plan also describes the plans for improving the quality of applications
to VGN and to extramural agencies and strategies to assist the faculty, including grant writing workshops
and intensive follow-up coaching for timely application submissions through our Professional
Development and Education (PDE) Core. Also with the PDE Core, the faculty will be provided with
mentoring by research advisors and the PDE Core Director, including the development of an Individual
Development Plan. VGN will continue to train BPI staff in grant management.
The Developmental Research Project Plan, coordinated with the PDE Core for mentoring and
coaching, uses some of the best practices that we have identified in use in other INBREs, such as
required grant writing workshops.
There are qualified investigators at all network Baccalaureate Partner Institutions, sufficient to
submit meritorious applications for our Project and Pilot Awards each year. We have long-term
experience with solicitation of proposals, assembly of review panels, review of applications, and
compliance with federal policies and guidelines.
Milestones have been set for improving of quality of applications to VGN and success in
applications to federal agencies and foundations. We continue to track our network faculty who have
been funded by VGN.